Mechanisms and functional implications of SARS-CoV-2 mRNA capping and modification.

SARS-CoV-2 must cap and methylate its mRNAs to ensure their stability, translatability, and avoid detection by host innate immune mechanism as non-self transcripts. The process of RNA capping, therefore, is pivotal to the success of a SARS-CoV-2 infection. It also represents a key contributor to the molecular mechanisms of pathogenesis as well as a very attractive target for the development of antiviral therapeutics. However, there are three key knowledge gaps that have slowed progress in our understanding of this important area of coronavirus molecular biology that will be addressed in this proposal. First, the identity of the guanylyltransferase (GTase), the centerpiece of the viral RNA capping machinery that transfers GTP to the 5' end of the nascent transcript, is unknown. We will use a two-pronged strategy of complementary molecular and biochemical approaches to address this glaring gap in our understanding of SARS-CoV-2 mRNA capping mechanisms, laying the foundation for the development of capping-targeted antivirals. Second, while RNA capping is a regulated process and uncapped RNAs play an influential role in the biology of other positive sense RNA viral infections, it is not known if RNA capping is a regulated or a default event in coronaviruses. We will determine if uncapped RNAs are produced by SARS-CoV-2 in order to establish the foundation for a role of regulated capping and non-coding viral transcripts in SARS-CoV-2 infections. Finally, every cellular mRNA that begins with a terminal adenosine has that residue 2'O methylated at the ribose ring as well as N6 methylated on the adenosine base (m6Am). The strong conservation of this m6Am modification indicates its importance in cell biology, an assertation recently confirmed with data suggesting that the modification increases translatability and facilitates recognition of the transcript as `self'. Interestingly, SARS-CoV-2 and other coronaviruses all initiate their transcripts with an A residue, but it is not known whether that A residue contains an m6A modification. In the final part of this project, we will determine the m6A modification status of the terminal 5' A residue of SARS-CoV-2 mRNAs and investigate the role that the modification (or lack thereof) plays in the biology of coronaviral transcripts. Collectively these studies will provide important new insights into the molecular biology of SARS-CoV-2 and open up avenues for the development of broad-spectrum anti- coronaviral therapeutics.

Public health relevance
Attractive avenues for the development of SARS-CoV-2 antiviral therapeutics are to attack and inhibit fundamental processes in viral gene expression, RNA stability, and avoidance of non-self recognition of viral transcripts by natural cellular molecular defense mechanisms. Interestingly, one viral process – mRNA capping and methylation – impacts all three of these avenues. In order to effectively exploit viral RNA capping as a target for antiviral development, we need to solve three knowledge gaps – all of which will be addressed in this proposal using complementary approaches to maximize our chances of success. First, we surprisingly do not know the identity of the main enzyme that put the cap on coronaviral transcripts. Second, we need to understand the contribution of the regulation of RNA capping to the viral infection. Finally, we need to fully understand the range and impact of methylations that decorate the base adjacent to the coronaviral cap as these decorations are thought to greatly influence cap functions in the cell. Collectively this work will lay a foundation for novel avenues of antiviral drug development.